Administrative Core

ABSTRACT – DUKE CANCER INSTITUTE ADMINISTRATION
Duke Cancer Institute Administration (DCI-A) supports the Duke Cancer Institute’s Executive Director, senior
leaders, program leaders, shared resource leaders, and members to ensure strong service interactions and
communications between all constituents across the research, clinical, education, community engagement and
outreach areas. The DCI leadership creates the overall strategic direction and research mission for DCI and the
Administration operationalizes their vision. DCI Administration’s mission is to promote all activities including
strategic planning, coordinated, transparent and outstanding operations that serve the high-level scientific goals
of the DCI. The DCI administration team oversees all research administration, clinical research, financial, human
resources, strategic planning, community engagement, outreach, education, communication, philanthropy,
informatics and IT operations, training and education of DCI.
DCI Administration played a major leadership role in DCI and Disease Focus Group Strategic Planning.
Additional accomplishments over this grant period include the reorganization and expansion of the administrative
team to improve operations, under the direction of a new Associate Director of Administration. In collaboration
with the DCI Deputy Director, administration now includes oversight of the Office of Health Equity and, in
collaboration with the AD for Training, the new DCI Office of Cancer Research Career Development. DCI-A
also established a new organizational structure for the Clinical Research Unit and its services, study
coordination, Quality Assurance, Scientific Protocol Review, Compliance, Safety, Regulatory and Training.
DCI was able to grow its cancer research activities with a 44% increase ($16M) of institutional support from
Duke Health and School of Medicine to support operational infrastructure, provide funds for recruitment and
retention, and provide support for protected academic time for DCI faculty. During the funding period, over $75M
in philanthropic support was provided to the DCI by a dedicated Development team, including over $19 million
in 2017 alone. In 2017, DCI supported the training, education and fellowship grants by providing an additional
$8.1M. DCI provided an average of $776,000 per year to support lectures, seminars and supplementary
educational activities. The DCI Administration serves 304 members, 14-shared resources and 8 programs across
34 academic departments within 7 schools, and oversees over 300 non-clinical staff to support the academic
mission. DCI-A directly manages over $36.5M in annual operating funds, of which $6.3M is philanthropic funds,
directly supporting CCSG research programs, shared resources and the clinical research office. In addition, DCI-
A oversees $110M in clinical research contracts, 330,502 sf of research, office and shared resource space.